Structure-function cell atlas for norepinephrine and serotonin neurons

Project Abstract
Norepinephrine (NE) and serotonin (5-HT) are neurotransmitters released by a small number of neurons in the
locus coeruleus (LC) and dorsal raphe (DR), respectively. Each group of neurons provides extensive
innervation of most of the brain. Although these groups of cells are often considered to be homogenous, recent
data indicates the existence of subclasses of each neuron. This proposal aims to generate multi-scale data on
each system, comprising molecular, genetic, anatomical, physiological, and behavioral experiments. Our team
is in a unique position to integrate across experiments and develop a new understanding of the subclasses of
LC-NE and DR-5-HT neurons and their functions during behavior.
Three aims test specific questions about the cell types and functions of LC-NE and DR-5-HT neurons in
mice: 1) LC-NE neuron subclasses have distinct biophysical properties and axonal projections; 2) subclasses
of DR-5-HT neurons have distinct biophysical properties and axonal projections; and 3) subclasses of LC-NE
and DR-5-HT neurons have different functions during dynamic decision making. Our experiments will be used
to develop a comprehensive classification of NE and 5-HT neuronal subclasses and will be used to generate
reagents to target those cells.

Public health relevance
Project Narrative This project aims to build a structure-function taxonomy of two key groups of neuromodulatory neuron types in the brain: neurons that release serotonin and those that release norepinephrine. Our co-laboratory will combine molecular, genetic, electrophysiological, morphological, and behavioral measurements to classify subtypes of serotonin and norepinephrine neurons and map their functions across the brain.